Germline targeting for neuraminidase broadly neutralizing antibodies

The development of a broad-spectrum inﬂuenza vaccine remains a signiﬁcant challenge. One promising target
for vaccine design is neuraminidase (NA), which is engaged by broadly neutralizing antibodies (bnAbs) that
mimic the sialic acid receptor and bind to the conserved active site. These NA bnAbs use long heavy chain
complementarity determining region 3 (HCDR3) loops to access the recessed active site. However, antibodies
with long HCDR3s are rare in the naive human antibody repertoire, making it unlikely for them to be consistently
elicited through standard vaccination strategies. To address this, a strategy called germline targeting vaccine
design aims to prime the rare precursor B cells with the potential to develop into bnAbs by giving them an afﬁnity
advantage over more common strain-speciﬁc competitors. In this proposal, recently discovered NA bnAbs will
be evaluated to assess their potential for germline targeting. Factors such as precursor frequency in the human
antibody repertoire, somatic hypermutation levels, and structural characteristics will be considered. Once the
most promising bnAb candidates have been identiﬁed, mammalian display directed evolution will be employed
to design NA immunogens that can engage diverse bnAb precursors from those NA bnAb classes. This protein
engineering effort will pave the way for future preclinical animal studies and other immunogen validation studies.
If successful, a demonstration that NA germline targeting immunogens can engage diverse NA bnAb precursors
would open up a new pathway towards a universal inﬂuenza vaccine.

Public health relevance
Inﬂuenza causes illness in millions of people every year and current vaccines have limited efﬁcacy. A vaccine that could elicit broadly neutralizing antibodies against both inﬂuenza A and B viruses would have a major impact on global health. The aim of this proposal is to engineer neuraminidase-based immunogens that are intended to priming broadly neutralizing antibody responses against type A and B inﬂuenza.